Measuring and manipulating metabolic fluxes in the tumor microenvironment

Measuring and manipulating metabolic fluxes in the tumor microenvironment
Tumors have altered metabolism compared to normal tissues, which suggests that drugging
metabolism could kill tumors while sparing healthy tissues. However, tumor metabolism has chiefly been
measured in vitro, while recent studies have showed that tumor metabolism in the body is distinct from in vitro
systems. Therefore, the field needs approaches to measure tumor metabolic fluxes in vivo. During my
postdoctoral fellowship, I developed methods to measure glycolytic and tricarboxylic acid cycle (TCA) flux in
vivo using kinetic infusion of isotope-labeled tracers. These approaches revealed that tumors have much lower
TCA flux than healthy tissues (5 mouse tumor models examined). Though the tumors had higher glycolytic flux
than healthy tissues, the total ATP production rate from glycolysis plus TCA cycle-driven oxidative
phosphorylation was significantly lower in tumors than in healthy tissues. Moreover, feeding mice a high-fat
ketogenic diet increased tumor TCA flux and slowed tumor growth synergistically when combined with
chemotherapy.
These findings raise two key questions. First, since tumors in vivo are a mix of cancer cells and other
infiltrating cells, what is the metabolism of cancer cells versus immune cells or fibroblasts in tumors? Second,
can directly upregulating tumor TCA flux slow tumor growth? I propose first to combine my glycolysis and TCA
cycle measuring techniques with immunomagnetic and sorting strategies to measure fluxes in cancer cells,
immune cells, and fibroblasts (Aim 1). I will apply this strategy to melanoma, a tumor type infiltrated by CD8 T
cells which can help control the tumor, and to pancreatic adenocarcinoma, a tumor type where fibroblasts and
myeloid cells can be even more abundant than cancer cells. Next, I will directly upregulate TCA flux in tumor
cells by using genetic and pharmacologic approaches: overexpressing the NADH uncoupler protein mito-
LbNOX, knockout of the TCA suppressor protein PDK, and inhibition of PDK with dichloroacetate. I will confirm
that these strategies increase TCA flux using the method I developed and will test whether increased TCA flux
slows tumor growth in primary and metastatic breast tumors. Successful completion of these aims will reveal
the metabolism of different cell populations in the tumor microenvironment and will test TCA upregulation as a
therapeutic strategy in cancer.

Public health relevance
My long-term goal is measuring how metabolism is altered in cancer so we can target cancer metabolism while sparing healthy tissues. Tumors are made up of a mix of cancer, immune, and connective tissue cells, which all play a role in supporting tumor growth, but the field has lacked approaches to measure metabolism in these different cell populations. I will use metabolic flux measurement techniques I have developed to measure the metabolism of each of the cell types living within the tumor, and to test whether targeting altered fluxes in cancer cells could slow tumor growth.